2/2 Neonatal Platelet Transfusion Threshold Trial (NeoPlaTT)

Abstract
Extremely preterm infants born at 23 to 26 weeks gestation have the highest incidence of thrombocytopenia
and bleeding and the highest mortality among neonates admitted to the Neonatal Intensive Care Unit (NICU).
Approximately 20% of extremely preterm infants develop a severe intracranial hemorrhage, almost always in
the first week of life, which is the highest risk period for bleeding. Platelet transfusions are frequently
administered to extremely preterm neonates at higher platelet count thresholds than those used in older
children and adults to decrease the risk of bleeding. Paradoxically, a recent multicenter randomized trial of
infants <34 weeks gestation conducted in Europe (PlaNeT-2) found that neonates randomized to a lower
platelet transfusion threshold of 25x10^9/L, compared to 50x10^9/L, had a significantly lower risk of death or
serious bleeding. However, 39% of infants received one or more platelet transfusions before enrollment, and
the median age at recruitment was 7-8 days, suggesting that a high proportion of thrombocytopenic infants in
the first week of life were not randomized before being transfused. This likely contributed to the persistent
uncertainty regarding optimal platelet transfusion thresholds, specifically in the most immature preterm infants
in the first week of life. In a recent survey, 57% of responding European NICUs continued to use thresholds
above 25x10^9/L in infants <28 weeks’ gestation and <7 days old. Another question raised by PlaNeT-2 was
whether thresholds lower than 25x10^9/L can be safely applied to extremely preterm infants after the first week
of life, when the risk of bleeding is much lower. The Neonatal Platelet Transfusion Threshold (NeoPlaTT) trial
was specifically designed to address these critical questions and will test the hypothesis that, among extremely
preterm infants born at 23 to 26 weeks gestation, a low platelet transfusion threshold, compared to a high
threshold, will improve survival without major or severe bleeding up to 40 weeks postmenstrual age. The
Specific Aims will (1) determine the comparative effectiveness of low platelet transfusion thresholds
(25x10^9/L in the 1st week of life, 20x10^9/L thereafter), compared to high thresholds (50x10^9/L in the 1st
week, 35x10^9/L thereafter), on the risks of death or major/severe bleeding for infants born at 23 to 26 weeks
gestation; (2) determine the comparative effectiveness of high vs. low thresholds on mortality as a key
secondary outcome, along with serious morbidities and need for platelet transfusion. Importantly, the trial will
be conducted in the NICHD Neonatal Research Network, which is a consortium of NICUs with established site
research infrastructure and extensive experience conducting multicenter clinical trials with early recruitment of
high-risk neonates. If our hypothesis is confirmed, this trial will change the current paradigm regarding the
liberal use of platelet transfusions to prevent bleeding towards the avoidance of unnecessary platelet
transfusions in this population. Most importantly, knowledge generated from the NeoPlaTT trial may improve
outcomes in our most vulnerable patients, while also decreasing costs and conserving resources.

Public health relevance
Project Narrative Babies who are born extremely premature commonly have low blood platelet counts and a high risk of bleeding, usually in the brain or lungs. For this reason, they commonly receive platelet transfusions to decrease the risk of bleeding, although a recent randomized trial suggested that premature babies who received less platelet transfusions had less bleeding and mortality than those transfused with a higher threshold. This has generated uncertainty among clinicians regarding the optimal platelet transfusion thresholds for extremely preterm infants, and this trial is specifically designed to address this uncertainty by evaluating if lower thresholds for platelet transfusions will lead to improved survival without bleeding among extremely preterm infants born at 23 to 26 weeks gestational age.